NATURAL HISTORY OF RAYNAUDS SYNDROME

The principal objective is to follow patients with Raynaud's syndrome over an extended period of time to determine the natural history and incidence of associated diseases.